Exploring mechanisms of axon growth and circuit connectivity for promoting respiratory function recovery following cervical spinal cord injury

Project Summary / Abstract (30-line maximum).
A majority of traumatic spinal cord injury (SCI) cases occur in the cervical spinal cord, resulting in persistent
diaphragmatic respiratory dysfunction that is associated with mortality, a host of morbidities such as respiratory
infections, and greatly reduced quality of life. Diaphragm is directly controlled by phrenic motor neurons
(PMNs) located at levels C3-5. PMNs are mono-synaptically activated by supraspinal brainstem neurons
located in the rostral Ventral Respiratory Group (rVRG). Cervical SCI results in axotomy of descending rVRG
fibers, denervation and silencing of spared PMNs, and partial-to-complete hemi-diaphragm paralysis.
In this Competing Continuation (“Renewal”) application, we aim to promote reconnection of rVRG-PMN-
diaphragm circuitry in a rat model of cervical SCI, a critically important therapeutic goal for individuals with SCI.
We developed inhibitory peptides against PTEN (phosphatase and tensin homolog: a central inhibitor of
neuron-intrinsic axon growth potential) and PTPσ (protein tyrosine phosphatase-sigma: an axonally-expressed
receptor that mediates the neuron-extrinsic axon growth inhibitory effects of chondroitin sulfate proteoglycans).
Our exciting preliminary findings show that systemic delivery of these peptides each result in robust – but
partial – recovery of diaphragm function in the C2 hemisection model of SCI. These initial studies also provide
compelling data suggesting that PTEN and PTPσ inhibition may promote recovery via different modes of rVRG
axon growth: (1) robust regeneration of injured ipsilateral rVRG axons with PTEN inhibition; (2) extensive
sprouting of spared contralateral rVRG axons into the PMN pool (ipsilateral to the lesion) with PTPσ inhibition.
Importantly, we do not understand which modes of axon growth can promote recovery of diaphragm
function after SCI, which significantly limits ability to develop targeted therapies. To address this critical issue,
we will use chemogenetic DREAAD manipulations to selectively-silence defined neuronal populations involved
in respiratory control in order to determine the mode(s) of circuit re-connectivity that causally drive recovery in
response to PTEN and PTPσ manipulation. We will target PTEN and PTPσ with systemic delivery of inhibitory
peptides and rVRG neuron-specific transduction with AAV-shRNA. We will compliment this approach using an
array of cutting-edge functional and axonal/synaptic tracing methods to assess rVRG-PMN circuit plasticity.
We hypothesize that stimulating (1) regeneration of injured rVRG axons, (2) sprouting of spared fibers
originating in contralateral rVRG, and (3) synaptic connectivity of these growing rVRG axons with PMNs
(located caudal to the lesion) will causally promote recovery of diaphragmatic respiratory function following
cervical SCI. We also hypothesize that the combination of rVRG axon regeneration and sprouting of spared
rVRG fibers will promote robust diaphragm recovery in the clinically-associated cervical contusion SCI model.
We will acquire an in-depth understanding of how modulating axon growth inhibition can induce rVRG-
PMN circuit plasticity and, importantly, which modes of connectivity promote diaphragm recovery after SCI.

Public health relevance
Project Narrative / Relevance A majority of human spinal cord injury (SCI) cases occur in the cervical region, resulting in persistent respiratory dysfunction that is associated with mortality, morbidities such as respiratory infections, and greatly reduced patient quality of life. Cervical SCI disrupts the neural circuitry that controls the diaphragm (the major muscle of inspiratory breathing); however, axon regeneration and consequent restoration of this critical circuitry do not occur following SCI. In an animal model of cervical SCI, we will test strategies aimed at promoting recconection of this neural circuitry for restoring diaphragmatic respiratory function.